The role of IL-2 therapy for Relapsing-Remitting Chikungunya Arthritis

ABSTRACT
Chikungunya virus (CHIKV) is an alphavirus spread by mosquitos that causes persistent arthritis in
approximately one-fourth of patients. There is currently no evidence-based standard treatment for CHIKV
chronic arthritis. In the current proposal, we seek to identify a therapeutic target for relapsing-remitting arthritis
associated with CHIKV infection. Our Colombian cohort (n = 500) of patients affected by CHIKV affords a
unique opportunity to further understand the immunology of CHIKV arthritis flares. Our preliminary data
suggest that alteration of regulatory T cell (Treg) function may play a role in CHIKV arthritis pathogenesis.
Novel low-dose interleukin-2 (IL-2) based therapies for autoimmune disease have been shown to up-regulate
Tregs and may be of use in CHIKV arthritis flares. Our main goal is to further understand the role of IL-2 in
Treg populations in CHIKV arthritis. Our central hypothesis is that chronic CHIKV arthritis activity is
associated with deficient IL-2 mediated Treg levels and low-dose IL-2 is a potential therapeutic. This
hypothesis will be evaluated in two specific aims. In Aim 1, we will describe the role of IL-2 in Treg expansion
and corresponding arthritis severity during CHIKV arthritis flare vs. remission compared to non-arthritic
controls. In Aim 2, we will determine the role of IL-2 therapy in the treatment of CHIKV arthritis in a mouse
model. The impact of this research will determine the correlation between Tregs and CHIKV-associated
arthralgia. It may provide a pre-clinical evaluation of low-dose IL-2 therapy for CHIKV arthritis and insights into
the use of this novel therapeutic for viral arthritis in general.

Public health relevance
NARRATIVE The objective of this proposal is to further understand the role of interleukin-2 (IL-2) in regulatory T cell (Treg) populations in CHIKV arthritis evaluating patients from our Colombian cohort and a mouse model. Our central hypothesis is that chronic CHIKV arthritis activity is associated with deficient IL-2-mediated Treg levels and low- dose IL-2 is a potential therapeutic. In Aim 1, we will describe the role of IL-2 in Treg expansion and corresponding arthritis severity during CHIKV arthritis flare vs. remission compared to non-arthritic controls, and in Aim 2, we will determine the role of IL-2 therapy in the treatment of CHIKV arthritis in a mouse model in order to evaluate the potential value of low-dose IL-2 therapy for CHIKV arthritis.